Improving Emotion Dysregulation and Interpersonal Conflict Among Families of Adolescents with ADHD

Project Summary/Abstract
The proposal presents a four-year research career development program focused on the evaluation of the
RELAX (Regulating Emotions Like An eXpert) intervention for families of adolescents with attention-
deficit/hyperactivity disorder (ADHD), and the development of ecological momentary intervention (EMI)
procedures a cutting-edge approach to support skill rehearsal in real life via smartphone apps. The candidate
is currently an Assistant Professor of Psychology at Virginia Tech. The outline proposal builds on her previous
research and clinical experience working with families of adolescents with ADHD by providing training and
mentorship that will facilitate her growth in four areas: (1) Developing proficiency in managing and responsibly
conducting clinical trials research; (2) Acquiring skills in the development and implementation of EMI; (3)
Gaining skills in data management and conducting longitudinal, multilevel analytic methods and clinical trial
analyses; and (4) Building community partnerships to ensure successful disseminating, implementing, and
sustainability of evidence-based interventions. The proposed clinical trial and didactic work will position the
candidate with a unique set of cutting-edge skills and statistical abilities that will enable her to transition to
independence as a clinical scientist conducting clinical trials research with families.
Adolescents with ADHD experience a host of negative outcomes, including risk for substance abuse,
suicidality, and mood disorders, partly due to the high levels of emotion dysregulation (ED) they experience.
Despite this, no evidence-based intervention exists for adolescents with ADHD that directly targets ED. As
such, the proposed research is both significant and innovative. Specifically, RELAX targets ED among families
of adolescents with ADHD in a brief, group-based intervention. In-person and telehealth pilot studies of RELAX
provide promising findings; however, the effectiveness of RELAX delivered through real world clinical settings
is needed. Families also indicated the desire for more opportunities to practice skills learned during RELAX in
focus groups following the pilot study; EMI could address this need. Despite EMI being used in other clinical
populations, EMI has not been explored among youth with ADHD, nor by simultaneously utilizing it with
parents and adolescents. This K01 will implement a small clinical trial to assess the acceptability, feasibility,
and preliminary efficacy of RELAX delivered by community clinicians relative to control. Additionally, it will
iteratively develop the EMI procedures to use in the future for skill rehearsal during and following RELAX. The
aims of this research are: (1) Quantify the acceptability, feasibility, and efficacy of RELAX relative to control at
post-intervention and short- and long-term follow-ups; (2) Identify the extent to which changes in RELAX main
outcomes during RELAX are associated with improvements in social-emotional and behavioral functioning at
follow-up; and (3) Identify stakeholder feedback on the EMI procedures. This study has potential to support
future independent research, and holds promise for transforming treatments for adolescents with ADHD.

Public health relevance
Project Narrative Adolescents with attention-deficit/hyperactivity disorder (ADHD) are at risk for a host of negative outcomes, in part due to the high levels of emotion dysregulation they experience. By examining the utility of an intervention targeting emotion dysregulation, and developing a tool to encourage practice of emotion regulation strategies in real life, this project holds significant relevance to public health and aligns with NIMH’s goals to advance mental health services to strengthen public health. Specifically, this K01 evaluates an easy to implement, brief psychosocial treatment for adolescents with ADHD that holds considerable promise for reducing the negative long-term outcomes and impairments common among this at-risk population.